Biostatistics, Analytics & Bioinformatics (BAB)

PROJECT SUMMARY/ABSTRACT (BIOSTATISTICS, ANALYTICS, AND BIOINFORMATICS)
Since its founding in 1986 the Biostatistics, Analytics and Bioinformatics (BAB) Shared Resource (SR) has
served as a cornerstone of the University of Michigan Comprehensive Cancer Center (UMCCC) research
community. This SR provides a group of highly trained biostatistics and bioinformatics personnel for consultation,
support and collaboration with UMCCC members who are conducting leading edge cancer research. Throughout
its history, a distinguishing feature has been its high-level of support for investigators across the spectrum of
basic, clinical and population sciences research, and exceptional collaboration as evidenced by the level of joint
grant funding and publications. In 2016 alone, the BAB SR personnel interacted with 139 UMCCC members and
were supported on 78 cancer-related research grants. During the project period, SR personnel were co-authors
on over 400 cancer-relevant research papers.